Chemotherapy-induced circadian master clock disruptions and fatigue

PROJECT SUMMARY/ABSTRACT
Understanding the causes and mechanisms underlying circadian rhythm disruptions that are associated with
fatigue during cancer treatment remains unclear. This current deficiency means that successful cancer treat-
ment falls short of its potential and prior quality-of-life remains elusive for patients. Our long-term goal is to im-
prove debilitating behavioral sequelae in cancer patients, thus improving quality-of-life, other comorbidities,
and mortality. Thus, the overall objective here is to establish the potential role of circadian disruption as a fun-
damental pathway by which chemotherapy promotes cancer-associated fatigue. Indeed, robust circadian rhyth-
micity of virtually all physiology is extremely well-conserved; desynchrony of these rhythms leads to negative
health and behavioral consequences. The central hypothesis is that chemotherapy-induced inflammation inhib-
its SCN function leading to fatigue. The rationale for this work is that circadian circuitry disruption is an under-
studied, relevant pathway in psycho-oncology research that could elucidate mechanisms and new, rhythm-fo-
cused interventions. Three specific aims are proposed to test the central hypothesis using our novel breast
cancer “survivor” mouse model. Aim 1 will determine the ability of the master clock to entrain after chemother-
apy. Behavioral SCN rhythm adaptations to environmental challenges will be assessed. Aim 2 will identify the
role of central inflammation in master clock disruptions after chemotherapy. The role of chemotherapy-induced
neuroinflammation on SCN molecular and behavioral rhythms will be quantified. The potential resolution of fa-
tigue will also be assessed. Aim 3 will determine the role of circadian disruption in chemotherapy-induced fa-
tigue. Genetic and pharmacological SCN timing manipulations will precede a battery of behavioral assess-
ments of the physical, motivation, and cognitive components of fatigue. In vivo and ex vivo circadian timing ap-
proaches combined with systems-, cellular-, and molecular-level analyses will pinpoint the effects of two regi-
mens of chemotherapy on master oscillator circadian circuitry relevant to cancer-related behavioral comorbidi-
ties. The proposed research is conceptually innovative because using circadian approaches is new to psycho-
oncology. It is also technically innovative by way of the superior translational model and the circadian genetic
and pharmacological techniques planned. This research will result in essential new knowledge about how com-
mon cancer treatments affect the pacemaker, which is crucial to extensive downstream physiology and behav-
ior (i.e., beyond fatigue). Results will provide much needed evidence to make circadian-based approaches
standard in clinical practice, as well as inform the design of novel circadian-directed pharmacological and non-
pharmacological interventions. This research is applicable to other cancers and in non-oncological populations
treated with chemotherapy (e.g., stem cell transplant, lupus).

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the elucidation of new mechanisms (i.e., chronobiology) will increase the understanding of the negative consequences of common drugs on brain and behavior. This mechanistic neuroscience cannot be done in humans. Thus, the proposed research is relevant to part of NCI/NIH’s mission that pertains to reducing cancer-related comorbidities, which in turn, improves health and quality of life.